Innate Immunity and Viral Infection in Asthma

In this AADCRC program renewal, we will focus on three critical and understudied innate immune factors
and how they impact viral infections in asthma: the anionic phospholipids of surfactant (palmitoyl-
oleoyl-phosphatidylglycerol, POPG, and phosphatidylinositol, PI), Toll interacting protein (Tollip), and
surfactant protein-A (SP-A). Because these mediators have complementary functions to modulate
inflammation and immunity in asthma and infection, we propose three interrelated, synergistic, self-standing
projects to investigate how these mediators orchestrate novel innate immune responses associated with viral
infections in asthma. We will study three viruses with a spectrum of effects in airway disease, and
determine how innate responses protect against them. Specifically, we will focus on rhinovirus C (RV-C), a
known exacerbator of asthma that can cause severe disease; influenza A, a virus whose effect in asthma remains
ambiguous and SARS-CoV-2, a virus that can cause severe lung disease, but for which asthma may not be a
risk factor, and may in fact confer protection. We show innovative preliminary data indicating that 1) POPG, PI
and SP-A attenuate RV-C infection; 2) Tollip exhibits protective effects as it is required for IL-13 to generate
soluble ST2 that in turn attenuates the effects of IL-33 during influenza A infection; and 3) SP-A and type 2
cytokines confer protection in the effector and initiation phases of SARS-CoV-2 infection in asthma by inhibiting
the expression and function of ACE2, the SARS-CoV-2 receptor, through effects upon transcription, receptor
binding and downstream pro-inflammatory signaling. Thus, all these innate immune components appear to
protect against viral infections in asthma. Our exciting preliminary data underpin our program’s overall
hypothesis that POPG/PI, Tollip and SP-A function as unique immune modulators that attenuate the
impact of specific viral infections (RV-C, Influenza A and SARS-CoV-2) in type-2 asthma. Therefore,
supplementation of functional POPG/PI, SP-A and the IL-33 decoy receptor sST2 may be novel strategies
against asthma exacerbations due to viral infections. Project 1 will critically test the activity of POPG/PI and SP-
A supplementation as a novel molecular tool for disrupting infections due to RV-C, a virus known to exacerbate
asthma. Project 2 will determine how Tollip protects against viral exacerbations caused by influenza A in asthma
through inhibition of IL-33 signaling. Project 3 will determine how type-2 cytokines and SP-A synergize to protect
against SARS-CoV-2 infection through inhibition of ACE2-mediated infection and IL-6 signaling pathways. We
also include an Administrative Core and a Clinical Core, both which serve all projects equally. We build upon
productive collaborations of over 20 years on innate molecular mechanisms underlying the interaction between
type 2 inflammation and viral exacerbations of asthma. The strong synergy among our three projects will
accelerate progress toward novel therapies by demonstrating that the innate immune components under
study protect against viral infection in asthma.

Public health relevance
PROJECT NARRATIVE: OVERALL This renewal of the Asthma and Allergic Disease Cooperative Research Center (AADCRC) program will continue to evaluate the still under-studied components of innate immunity and viral infection is asthma: Palmitoyl-oleoyl- phosphatidylglycerol (POPG), phosphatidylinositol (PI), Toll interacting protein (Tollip) and surfactant protein-A (SP-A) and their impact upon viral infections in asthma. The strong synergy and 20-year collaboration among the AADCRC’s three projects and project leaders will accelerate progress toward novel therapies by demonstrating that the innate immune components under study protect against viral infection in asthma.